Epidemiology of Malaria Invasion in Mutare City and Targets for Elimination, Zimbabwe

Epidemiology of Malaria Invasion in Mutare City and Targets for Elimination,
Zimbabwe
PROJECT SUMMARY/ABSTRACT
This award will enable Dr. Sungano Mharakurwa to ascertain the epidemiological determinants
of urban malaria invasion in Zimbabwe in order to identify intervention targets for restoring
malaria-free status. The study will leverage on an existing national malaria vector surveillance
programme established at Africa University in conjunction with the Ministry of Health and Child
Care’s National Malaria Control Programme and its partners. This work will be undertaken with
guidance from an experienced team of mentors with strong complementary expertise in public
health, epidemiology, transmission biology, parasite genetics, genomics and human studies. Dr.
Mharakurwa will further his career development by; 1) conducting and directing the laboratory
assays, 2) undertaking short courses in molecular epidemiology, quantitative and sequence
data analysis, translation research, conduct of clinical trials and grant-writing; and 3) presenting
at international research conferences and writing publications. The program will be pivotal in
enabling Dr. Mharakurwa to establish a career and strong collaboration as an independent
malaria researcher in Zimbabwe. While Zimbabwe has made significant progress rolling back
malaria, a serious setback of reinvasion from endemic to erstwhile malaria-free areas of the
country, including highly populated cities, is emerging. The proposed research project will
employ molecular and field approaches to understand the seasonal distribution, determinants
and characteristics of parasites, vectors and humans associated with urban malaria invasion
into Mutare City of Zimbabwe in order to identify strategies for reclaiming zero transmission.

Public health relevance
Project narrative Owing to the scale-up of control interventions, malarial burden has significantly declined in Zimbabwe and other endemic countries in the past ten years. However, the decline has been heterogeneous and a new setback of reinvasion from malarious to former malaria-free areas, including highly populated cities, is emerging. The goal of the proposed project is to employ robust molecular and field approaches to ascertain the vector, parasite and host-related determinants of urban malaria in order to identify targets for control interventions to restore malaria-free status. The project will leverage on existing malaria surveillance collaboration with the Ministry of Health and Childcare and its partners and will incorporate evaluation of control interventions over time. It also lays groundwork for development of larger follow-up research gearing towards ultimate attainment of malaria elimination by the country which is a member of the malaria elimination-8 (E-8) block.